Preventing TB with intravenous BCG in SIV-infected macaques

PROJECT SUMMARY
Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb) is the most common cause of mortality in HIV+
individuals. Although antiretroviral and antimycobacterial drugs have reduced the burden of TB in the HIV+
population, they are incompletely effective against this global health burden. The only available TB vaccine is
the live attenuated mycobacterium Bacillus Calmette-Guerin (BCG) that is given intradermally to infants. While
this provides substantial protection against non-pulmonary TB in childhood, it has little impact on pulmonary TB
rates in adults. However, we have shown recently that BCG delivered intravenously (BCG IV) conferred dramatic
protection from TB in SIV-negative macaques.
Dr. Scanga conducted a preliminary study of BCG IV in his macaque model of HIV/Mtb co-infection. Animals
infected with pathogenic SIV for several months that were then co-infected with virulent Mtb exhibited more
severe TB than did similarly-infected SIV-naïve animals. In their preliminary study, vaccination of SIV+ macaques
with BCG IV induced immunity that parallels that seen in SIV-naïve rhesus and conferred dramatic protection
from TB in 6/7 animals. Furthermore, there were no signs of disseminated BCG. This unprecedented
protection from TB in SIV+ animals provides exciting evidence that BCG IV can be safe, immunogenic,
and protective in NHP with chronic SIV infection
While these data are provocative, there is still much to learn about the mechanisms by which BCG IV provides
such striking protection. In this R01 proposal, we will extend these exciting results to refine the ability of BCG
IV to protect SIV+ macaques from infection with Mtb. Most importantly, we will use comprehensive
immunologic approaches, both biased and unbiased, to determine the immune correlates and mechanisms
of BCG IV-mediated protection against TB in the context of pre-existing SIV. This will demonstrate that it
may indeed be possible to protect persons infected with HIV from TB and will guide the development of TB
vaccine approaches that can protect this highly vulnerable population.
The team we have assembled includes experts in the field of TB, vaccines, and the cutting-edge technologies
that will allow us to understand better the remarkable protection of SIV+ animals with BCG IV. We already have
an established collaborative relationship and ensures successful completion of this very exciting study.

Public health relevance
PROJECT NARRATIVE Co-infection with HIV is one of the most common risk factors for developing tuberculosis (TB) and so we model HIV and M. tuberculosis (Mtb) co-infection in monkeys, using simian immunodeficiency virus (SIV) as an HIV surrogate, to study this. Our exciting preliminary data suggests that vaccinating SIV+ animals with intravenous Bacille Calmette-Guerin (BCG IV) confers remarkable protection from TB. Here, we will further evaluate BCG IV to better refine this vaccine regimen and to identify the mechanism of this striking protection.